SF1 neurons and sympathetic regulation of glucose homeostasis

PROJECT SUMMARY
Exercise induces a wider-range of physiological responses, such as the changes in skeletal muscle, hepatic
glucose metabolism and intermediary metabolism. These responses involve a coordinated multi-organ
crosstalk between the brain, liver and skeletal muscle. A region in the brain knowns as the ventromedial
hypothalamus (VMH) plays a critical role in the regulation of metabolism and the metabolic responses to
exercise .The VMH is thought to act primarily through the sympathetic nervous system (SNS) and the release
of catelcholamines, which then bind to adrenergic receptors in target tissues. We hypothesize that the VMH
mediates some of the metabolic benefits of exercise via the β2AR isoform in skeletal muscle, and the α1bAR
isoform in liver. The goal of this application is to investigate the contributions of these tissue-specific isoforms
to the metabolic benefits of exercise using novel genetically engineered mice and novel metabolic flux analysis
methods. We anticipate that the results from our investigation will provide novel insights into potential therapies
to combat metabolic disease.

Public health relevance
PROJECT NARRATIVE Exercise improves metabolism throughout the body. We propose that exercise stimulates the brain, which then sends signals through the sympathetic nervous system to the liver and muscle to regulate glucose levels. The goal of this application is to investigate this inter-organ crosstalk and how it responds to exercise. We anticipate that the results from our investigation will aid in the development of novel therapies for diabetes.